Microglial Phagocytosis of Dendritic Spines in Veterans with Schizophrenia

Schizophrenia (SZ) is a severe and chronic psychiatric illness characterized by cognitive dysfunction. SZ
has a higher prevalence in Veterans and is associated with increased disability and mortality in Veterans.
Genome-wide association studies have identified variants of microglia-related genes as risk factors for SZ.
How such genetic factors might be manifest as molecular alterations in microglia in SZ is not clear.
Understanding microglial function in SZ is important because microglia are involved in the phagocytosis of
dendritic spines on pyramidal neurons. Spines, which receive most of the excitatory input to pyramidal
neurons, are critical mediators of the cognitive functions that are impaired in SZ. Spine density is lower
principally in deep layer 3 of the prefrontal cortex (PFC) in SZ, and PFC layer 3 has been reported to subserve
cognitive processes affected in the illness. Thus, we hypothesize that the dendritic spine deficit in deep
layer 3 of the PFC in SZ is due to increased phagocytosis of spines by microglia.
Testing our central hypothesis requires answering the following questions. First, do microglia in SZ show a
profile of critical molecular features that enables increased spine phagocytosis (Aim 1)? We will quantify levels
of both newly discovered and established transcripts that are selectively expressed by microglia and are
involved in phagocytosis of dendritic spines (or the inhibition of phagocytosis) in laser microdissected deep
layer 3 of PFC area 46 in SZ (n=32; 50% Veterans) and unaffected comparison subjects (n=32; 50%
Veterans). We predict that SZ subjects have higher mRNA levels of microglia-specific markers that promote
spine phagocytosis and lower mRNA levels of markers that inhibit phagocytosis. We will also use a novel
quadruple-label RNAscope approach to quantify transcript levels in individual microglia to determine if all, or
only some, microglia show molecular alterations in SZ. We predict that transcripts promoting spine
phagocytosis are elevated in only a subset of microglia in SZ, which could account for findings that spine
density is ~20% lower and most prominent in deep layer 3 of the PFC in SZ.
Second, are spine deficits in deep layer 3 of the PFC in SZ associated with molecular and morphological
features that indicate increased spine phagocytosis in nearby individual microglia (Aim 2)? Microglia and their
associated processes have their own individual territorial organization, permitting the quantification of dendritic
spines located exclusively within the territory of an individual microglia. Therefore, in the same subjects studied
in Aim 1, we will use a quintuple-label confocal immunofluorescence microscopy approach to quantify the
density of spines identified using two markers within 3D sampling regions constrained to the territorial domain
of individual microglia. We will also quantify levels of CR3, which is involved in complement-mediated
microglial phagocytosis of spines, and CD68, a phagocytic marker, and microglial process volume and
complexity, which are associated with levels of spine phagocytosis, in individual microglia. We predict that
spine density is inversely correlated with CR3 and CD68 levels and microglial process volume and complexity
in nearby individual microglia in SZ subjects.
Investigating the relationship between microglia-mediated spine phagocytosis and spine deficits in SZ
will enable the pursuit of novel molecular targets for microglial inhibitors that may remediate dendritic spine
deficits and repair synaptic connectivity, and possibly cognitive dysfunction, in Veterans with SZ.

Public health relevance
Schizophrenia is a severe and life-long psychiatric disorder with a higher prevalence in Veterans relative to the general population. Veterans with schizophrenia have elevated rates of unemployment and disability which may be, in part, attributable to cognitive deficits. Cognitive deficits are difficult to treat and have been linked to dendritic spine deficits in the prefrontal cortex. The proposed studies investigate the pathophysiology of cognitive dysfunction in schizophrenia by testing the hypothesis that spine deficits are due to increased phagocytosis of spines by microglia. We test this hypothesis by determining if microglia show molecular features that enable elevated spine phagocytosis and if molecular and morphological indicators of elevated spine phagocytosis in individual microglia are inversely related to neighboring spine density in schizophrenia. These studies will help identify novel targets for microglial inhibitors that may disrupt microglial-mediated spine phagocytosis, repair synaptic connectivity, and improve cognitive function in Veterans with schizophrenia.